Role of formaldehyde, formate and one-carbon metabolism in the female heart

PROJECT SUMMARY
Cardiovascular disease is the leading cause of death among men and women in the United States. Recent
epidemiological findings support an intrinsic mechanism that protects pre-menopausal women from many
cardiovascular pathologies and this protection is lost with menopause. Similar protective effects have been
observed in preclinical models, suggesting that an understanding of the normal biology of the female heart could
yield insight for effective cardiovascular therapeutics in humans. Recent work from our group demonstrates that
free formaldehyde levels are two-fold higher at baseline in female hearts vs. males. Formaldehyde is a highly
reactive electrophile produced as a byproduct of many cellular metabolic reactions and is known to induce
cytotoxicity by forming adducts with DNA and protein. To counteract this cytotoxicity, formaldehyde
dehydrogenase (FDH or GSNOR) and mitochondrial aldehyde dehydrogenase 2 (ALDH2) have evolved to
oxidize formaldehyde to formate, which can act as a one-carbon source. One-carbon metabolism is essential for
generating the building blocks required for amino acid, purine and thymine biosynthesis, but also for generating
critical antioxidants and maintaining tetrahydrobiopterin (BH4), which is essential for nitric oxide synthase (NOS)
function. Interestingly, female hearts exhibit increased FDH and ALDH2 activity vs. males, as well as higher
endothelial NOS (eNOS) activity. Our preliminary findings show that FDH activity and formaldehyde levels
decrease with ovariectomy (OVX) in female hearts, suggesting that endogenous formaldehyde is sex hormone-
dependent. As such, the formaldehyde-formate arm of the one-carbon cycle may represent a resilient
mechanism that benefits and protects female hearts by turning cytotoxic formaldehyde into formate to maintain
BH4 levels and NOS activity, but this mechanism has not been examined in female hearts. Furthermore, we were
the first to discover that the loss of FDH exacerbates ischemic injury in female hearts, resulting from a two-fold
increase in post-ischemic formaldehyde, but ALDH2 activation rescued this injurious phenotype in female
FDH-/- hearts. These results suggest that alterations to FDH activity and/or formaldehyde can drive myocardial
pathology in females, but additional studies are needed to define a novel role for the formaldehyde-formate one-
carbon arm in the biology of the female heart. This proposal will address this important knowledge gap in the
following specific aims: 1) define the source and localization of endogenous formaldehyde generation in female
hearts and 2) define a potential link between the formaldehyde-formate one-carbon arm and eNOS function in
female hearts. If completed successfully, this study will advance our mechanistic understanding of the
formaldehyde-formate one-carbon arm in the female heart and provide valuable insight into how this pathway
may be targeted for the therapeutic treatment of cardiovascular disease.

Public health relevance
PROJECT NARRARTIVE Cardiovascular disease is the leading cause of death among men and women in the United States and is accompanied by a tremendous healthcare burden. Epidemiological studies and preclinical models support the existence of an intrinsic, nitric oxide-dependent cardioprotective mechanism in pre-menopausal female hearts, but our understanding of this mechanism is incomplete. This proposal will investigate a potential link between the formaldehyde-formate arm of the one-carbon cycle and the production of nitric oxide as a resilient mechanism to drive cardioprotection in female hearts and provide therapeutic insight into the treatment of ischemic heart disease in males and females.